POSTMENOPAUSE ESTROGEN/PROGESTIN SAFETY AND FOLLOWUP STUDY

PEPI followup study to follow women who recently completed the three year postmenopausal estrogen/progestin intervention (PEPI) study. The study will monitor women for delayed onset of problems that could be related to study medications.